Ovarian disrupting effects of per-and polyfluoroalkyl substances (PFAS) on gonadotropin-dependent folliculogenesis and ovulation

PROJECT SUMMARY
The per- and polyfluoroalkyl substances (PFAS) are human-made organic compounds that are widely used in
consumer and industrial products. The strong C-F bonds of PFAS make them highly resistant to environmental
degradation and thus earn PFAS the name “Forever Chemicals. Humans can be exposed to high levels of PFAS
through drinking water and foods in areas near the contaminated sites. PFAS are rarely metabolized once
absorbed, with half-lives as long as 8-9 years. Epidemiological evidence revealed associations between PFAS
and female ovarian disorders, such as premature ovarian failure (POF), irregular menstrual cycles, and infertility,
but the underlying mechanisms remain elusive. So far, nearly all studies focused on perfluorooctanoic acid
(PFOA) and perfluorooctane sulfonate (PFOS), two long-chain legacy PFAS that have been phased out. The
ovarian toxicity (ovotoxicity) of other widely used long-chain PFAS such as perfluorononanoic acid (PFNA) are
rarely studied, despite some may have similar or even higher contamination levels. In the real world, humans
are exposed to PFAS mixtures, but their ovarian impacts are poorly characterized. Our recently published studies
and preliminary data support ovotoxicity of PFAS. (1) A cross-sectional epidemiological analysis of the NHANES
dataset revealed positive associations between serum concentrations of long-chain PFAS and long-term
amenorrhea in women of reproductive age; (2) In an in vivo mouse exposure model, PFNA accumulated in the
ovary to levels observed in women, and PFNA dose-dependently inhibited ovulation; (3) In an in vitro mouse
ovarian follicle culture system, PFNA concentration-dependently inhibited follicle maturation and ovulation; and
(4) A selective antagonist of peroxisome proliferator-activated receptor gamma (PPARγ) rescued PFNA-blocked
ovulation in both in vitro and in vivo models. With these findings, we will test our central hypothesis that: (1) at
environmentally high but human-relevant exposure levels, PFNA acts primarily as a PPARγ agonist, as the
molecular initiating event (MIE), in follicular granulosa cells to interfere with folliculogenesis, leading to impaired
ovarian functions and female reproduction; (2) also via PPARγ-mediated MIEs, PFAS of major public health
concern and their mixtures produce similar ovotoxic effects but with different potentials. We will integrate in vivo,
in vitro, and in silico models to test our hypotheses in three Specific Aims. In Aim 1, we will use a mouse model
of natural ovarian cycles and human-relevant doses and duration of PFNA exposure via drinking water to
investigate ovarian disrupting effects of PFNA and female reproductive outcomes. In Aim 2, we will study the
mechanistic and causal roles of PPARγ in PFNA-induced ovarian follicle maturation and ovulation defects. In
Aim 3, we will use experimental and computational models to determine the ovotoxicity of PFAS singles and
mixtures of major health concern. This research is highly innovative and significant given the emerging concern
of PFAS on female reproduction. Elucidating the ovotoxicity of PFAS will enable us to speed up the development
of prevention, mitigation, and remediation methods to protect female reproductive health and fertility.

Public health relevance
PROJECT NARRATIVE The goal of this project is to investigate the female reproductive impacts of per-and polyfluoroalkyl substances (PFAS) and mixtures, particularly for their effects and mechanisms on gonadotropin-dependent folliculogenesis and ovulation. This study is greatly important to evaluate the risk of exposure to single PFAS and mixtures on female reproductive health and fertility as well as to develop the prevention, mitigation, and remediation methods.